Regulation of the intestinal colonization niche by epithelial cell death

Project Summary
The intestinal microbiome is made up of trillions of microorganisms that inhabit the gastrointestinal tract.
Metabolites produced by the microbiome reach extraintestinal tissues, and can be found in the bloodstream, and
are thereby able to influence almost all tissues of the body. Interestingly, the expression of a number of genes
of the gastrointestinal tract is dependent on colonization by the microbiome. In this project, we will explore the
mechanisms through which the gut microbiome controls gene regulation of intestinal epithelial cells (IECs),
through the study of a microbiome-modulated gene involved in IEC cell death. Salmonella enterica serovar
Typhimurium (STm) is a pathogen that is adept at overcoming host defenses in order to cause disease. STm
triggers an inflammatory response that benefits growth of the pathogen by taking advantage of the host response
to infection. Our preliminary findings suggest that STm is able to benefit from a homeostatic microbiome-
mediated cell death pathway that has yet to be described. Under steady state conditions, metabolites produced
by the microbiome lead to pyroptosis of IECs, which helps maintain normal epithelial turnover. However, upon
STm infection, the pathogen harnesses this pathway to elicit increased IEC pyroptosis, leading to increased STm
numbers in the gastrointestinal tract. Our early results indicate loss of components of the IEC pyroptosis pathway
led to lower STm luminal outgrowth and dissemination to extraintestinal organs, yet, it is unclear how STm
activates IEC pyroptosis, and whether this pathway indeed leads to an increase in pyroptosis of intestinal
epithelial cells during infection. Thus, I hypothesize that during infection of the gastrointestinal tract, STm takes
advantage of a microbiome-controlled homeostatic IEC-specific cell death pathway to bloom to high numbers.
In order to elucidate how the microbiome and STm activate IEC pyroptosis, and how this activation leads
to cell death and downstream pathogen expansion within the gastrointestinal tract and in extraintestinal sites,
we propose two specific aims. In AIM 1 we will assess the contribution of the gut microbiome to induction of IEC
pyroptosis, by using a combination of sequencing and in vivo mouse models using conventional and gnotobiotic
mice. In AIM 2 we will use mouse infection models to determine how STm elicits IEC pyroptosis during infection,
and define the upstream activation pathway. Our mechanistic approach will provide a causal link between the
microbiome, a host cell death pathway, and pathogen expansion. Successful completion of this proposal will
identify a previously undefined IEC cell death pathway that plays a crucial role under steady state and infectious
conditions. This project will additionally expand my training to include key methods and concepts in IEC biology
and in the study of the microbiome. Altogether, the research and training plan proposed will facilitate a better
understanding of IECs and their role in host immunity, while preparing me for a future career as an independent
investigator in the field of host-microbe interactions.

Public health relevance
Project Narrative The mechanisms by which the gastrointestinal microbiota influences host immunity remain poorly characterized. The intestinal epithelial cells integrate information from the microbiota, and relay these signals to the downstream immune system, therefore playing a key role as intermediaries in the effect of the microbiota on the entire body. In this project, we propose to study how the microbiota regulates intestinal epithelial cell death and how this can influence disease susceptibility and infectious disease outcomes with the goal of furthering our understanding of epithelial cell function, which will aid the design of new therapies to restore host immune function.